MELATONIN SUPPRESSION BY LIGHT IN AFFECTIVE DISORDER

To see if bipolar patients have increased sensitivity to suppression of melatonin upon exposure to light. Effects of lithium on suppression in bipolar patients upon exposure to light.